Supervised Weighted Distances: Patient Similarity to Explain Clinical AI Models

Summary
Explaining complex, multivariate predictive models to clinicians and life scientists is difficult, but it is necessary
to increase their trust and to allow them to properly apply the model to data from their own patients or study
participants. Although certain model visualizations may be helpful for data scientists, they are not always helpful
for clinicians and life scientists. Explaining that similar patients get similar estimates and visualizing such patient
neighborhoods in a consistent manner, regardless of the type of underlying model (e.g., logistic regression,
random forests, deep neural networks, etc.) may be helpful to them.
In the context of a specific predictive model (e.g., a polygenic risk score, a deterioration index), seemingly very
dissimilar patients may get close estimates if many variables are considered: there could be a mismatch between
a neighborhood-based explanation and model behavior. A way of preventing this mismatch is to build context-
based patient neighborhoods for visualization. Context is captured by considering for the construction of patient
neighborhoods only the dimensions (or variables) that are important for the predictive model.
We find that context-based visualizations can work for deep neural network models based on real-world data
and we propose to develop robust algorithms (using both data- and clinical-knowledge-driven approaches) and
a tool that will help clinicians and life scientists understand the estimates of predictive models by looking into
these patient neighborhoods built from supervised weighted distances for different clinical problems. We also
propose to develop versions of the algorithms that can work with federated databases in a privacy-protecting
manner.
Our algorithms and tools will be developed in coordination with clinician-informaticians who will select relevant
models, develop representative test cases, and help recruit clinicians for a formative evaluation. We will develop
and evaluate our visualization tool under the guidance of human-computer interaction experts. We expect the
neighborhood-based explanation to be intuitive and interactive, so clinicians can ask “what if” questions and
explore the placing of various patients in models built for their clinical domains: emergency medicine, pulmonary
medicine, pediatrics, internal medicine and endocrinology medicine. These models can be ones developed in-
house by our team or by others: the privacy-protecting federated version of our algorithm and tool will allow the
proposed visualizations to work even without having direct access to the database of patients used to build the
models.

Public health relevance
Narrative Predictive models for use by clinicians are increasingly available via electronic health record systems, but many clinicians do not understand and do not trust them. We propose novel algorithms and tool that uses interactive visualizations of similar patients to explain predictive models to clinicians.